Efficacy of Methylphenidate for Management of Long-term Attention Problems inTBI

DESCRIPTION (provided by applicant): Attention deficit hyperactivity disorder (ADHD) is a risk factor for pediatric TBI and often persists post-injury. TBI may also produce attention deficis de novo (secondary ADHD [SADHD]). When combining pre-TBI ADHD and SADHD rates, the prevalence of post-injury ADHD is near 40-45%. First line medication treatment for primary ADHD is methylphenidate, but the use of methylphenidate for attention problems after pediatric TBI is highly variable. Only two clinical trials evaluating the efficacy of methylphenidate on attention problems after pediatric TBI have been performed and the results have been inconclusive. The inconclusive results may be due to limitations of small sample sizes, inadequate dose titration, and inadequate evaluation of potential mediating and moderating factors. This proposal will begin to address these knowledge gaps. The objectives of the study are to (1) determine the efficacy and dose-response of methylphenidate treatment of attention problems after pediatric TBI and (2) provide a better understanding of the relationship of a prior history of ADHD, ADHD subtypes after TBI, executive function, and attentional control to treatment efficacy. The proposed clinical trial will enroll 50 children, age 6-17 years, with attention problems 12-48 months after moderate to severe TBI into a randomized, double-blind, placebo-controlled, cross-over design trial with 3 dose conditions (low, medium, and high). The study will characterize the response of attention problems after pediatric TBI to methylphenidate (primary analysis) and evaluate potential mediating and moderating factors of treatment response (secondary analyses). The study will add new and innovative information to the pediatric TBI literature. It will provide a better understanding of the efficacy of methylphenidate for treatment of attention problems after pediatric TBI and it will elucidate clinical profiles tha may influence response to treatment. The findings have the potential to directly impact clinical management. Findings will also inform the development of larger studies that will facilitate the development of individualized protocols for management of attention problems after pediatric TBI. The study also builds on the candidate's prior research that has evaluated predictors and moderators of cognitive and behavioral outcomes after pediatric TBI. It will provide him with new skills and knowledge that will allow him to move beyond evaluating moderators of outcomes. This proposal will provide the candidate with new expertise in the development, conduct and analysis of clinical trials, improve his knowledge of neuropharmacology, and further develop his knowledge of the assessment of cognitive and behavioral outcomes after pediatric TBI. The candidate's expertise in these areas will be facilitated through a training plan that incorporates didactic course work, directed mentoring, and guidance from his mentoring team on manuscript and future grant preparation. At completion of the project, the candidate will be poised to develop clinical trials to individualize the management of neurobehavioral and cognitive sequelae of pediatric TBI.

Public health relevance
PUBLIC HEALTH RELEVANCE: Attention problems after traumatic brain injury (TBI) in children often lead to difficulties in multiple settings. This project will determine the effectiveess of methylphenidate for treatment of long-term attention problems after pediatric TBI. The influence of clinical characteristics of attention problems on treatment effectiveness will also be evaluated. Findings from the study have the potential to directly impact clinical care. __SpecificAimsTextDelimiter__ Specific Aims: Traumatic brain injury (TBI) is a worldwide health problem and among the leading causes of acquired morbidity and mortality in children in the United States. Attention problems are common after injury and are associated with long-term problems in functioning across multiple settings. Attention deficit hyperactivity disorder (ADHD) is a risk factor for pediatric TBI and often persists or worsens post-injury. TBI may also produce attention deficits de novo. Rates of pre-TBI ADHD are approximately 20-30% and rates of ADHD after TBI in children without a pre-injury history of ADHD (secondary ADHD [SADHD]) range from 15-20% during the initial two years post-injury. When combining pre-TBI ADHD and SADHD rates, the prevalence of post-injury ADHD is 40-45%. Currently, little evidence exists to guide pharmacologic treatment of attention problems after TBI in children. Although methylphenidate is the first-line treatment recommendation for children older than 6 years with primary or developmental ADHD, its efficacy for treatment of attention problems after pediatric TBI is unclear. Clinically, the use of methylphenidate for persistent ADHD and SADHD in children after TBI is common, but highly variable and evidence-based protocols have not been developed. Only two previous clinical trials have evaluated the efficacy of methylphenidate for attention problems after pediatric TBI and their results were inconclusive. Both studies used double blind, placebo-controlled, cross-over designs; however, they were limited by small sample size (10 and 14 subjects in each study), high variability in time since injury (range:1 to 60 months), and a single medication dosage. Additionally, the influence of a prior history of ADHD, characteristics of attention problems after injury, and neurocognitive problems such as executive dysfunction and deficits in attentional control (inhibitory response control and processing speed) on treatment efficacy were not examined. In contrast, studies of children with developmental ADHD provide evidence of varied individual responses at different dosing levels (i.e., low, medium, or high). Some individuals require higher doses to achieve optimal response. Moreover, certain profiles of attention problems correlated with better treatment efficacy. In summary, current understanding of pharmacological management of attention problems after pediatric TBI has been hampered by small sample sizes, lack of dose titration, and inadequate evaluation of potential influences on treatment response. This proposal will begin to address these knowledge gaps. The objectives of the study are to (1) determine the efficacy and dose-response of methylphenidate treatment of attention problems after pediatric TBI and (2) provide a better understanding of whether a prior history of ADHD, ADHD subtypes, executive functioning, and attentional control influence treatment response. The proposed clinical trial will enroll 50 children, age 6-17 years, with attention problems 12-48 months after moderate to severe TBI into a randomized, double-blind, placebo- controlled, cross-over design with 3 dose conditions (low, medium, and high). We will characterize the response of attention problems after pediatric TBI to methylphenidate (primary analysis) and evaluate potential mediating and moderating factors of treatment response (secondary analyses). Specific Aim 1 (Primary analysis): Determine the efficacy of methylphenidate for treatment of attention problems after pediatric TBI. Hypothesis 1: Methylphenidate will significantly reduce attention problems after pediatric TBI as assessed by parent and teacher attention scale ratings. Increasing doses will be associated with greater reduction in parent and teacher attention scale ratings. Exploratory Aims (Secondary analyses) Aim 1.1: Determine whether a prior history of ADHD and ADHD subtypes moderate treatment response. Hypothesis 1.1a: A pre-injury history of ADHD will be associated with an improved response to methylphenidate treatment across all dosing conditions. [Hypothesis 1.1b: The inattentive subtype of ADHD will be associated with an improved response at lower doses while combined and hyperactive subtypes will be associated with an improved response at higher doses.] [Aim 1.2: Determine whether executive functioning and attentional control mediate treatment response of attention scale ratings to methylphenidate. Hypothesis 1.2: Improvements in parent and teacher attention scale ratings with methylphenidate treatment will be mediated through improvements in executive functioning and attentional control.] [This study will add novel and innovative information to the pediatric TBI literature. It will be the largest and most homogenous study evaluating the efficacy of methylphenidate for treatment of chronic attention problems after moderate to severe TBI in children. Additionally, it will be the first study to evaluate dosing effect and potential mediators and moderators of methylphenidate treatment for attention problems after pediatric TBI. The findings have the potential to improve clinical care by guiding management based on clinical profiles at an individual level. At the completion of this project, the candidate will be poised to address the critical need for larger, multi-site clinical trials to inform and individualize the management of neurobehavioral and cognitive sequelae of pediatric TBI.]